Catalysis and inhibition of chitin synthesis from pathogenic fungi

Project Summary/Abstract
The available antifungal drugs against invasive fungal infections are limited due to the challenge in selectively
killing eukaryotic pathogens without harming humans. Chitin synthases (CHSs) represent one of few proven
targets whose inhibition provides highly selective antifungal effects without any detectable toxicity to humans.
CHSs are transmembrane processive glycosyltransferases (GTs) responsible for the biosynthesis of chitin, an
essential polysaccharide component of the fungal cell wall. Due to their essential function in fungal physiology,
CHSs are targeted by naturally occurring peptidyl nucleoside (PN) antifungal agents. PNs exhibit in vivo activities
against multiple endemic fungal pathogens without adverse effects on humans, and exhibit a strong synergy with
current FDA-approved antifungal drugs. However, their development has been slow because of only moderate
antifungal activities against more clinically prevalent fungal pathogens such as Candida albicans and the
absence of atomic-level understanding of CHS. Our long-term goal is to provide a comprehensive understanding
of CHS catalysis, regulation, and inhibition at the atomic level. The current application focuses on structural and
mechanistic studies of the catalysis and inhibition of C. albicans CHSs. C. albicans has four CHSs of which
CaCHS1 and CaCH2 require simultaneous inhibition for fungicidal effects. While existing PNs potently inhibit
CaCHS2, they are much weaker against CaCHS1 and thus exhibit only moderate antifungal activity against C.
albicans. The molecular mechanism behind the difference in PN potency between CaCHS1 and CaCH2 is
currently unknown. For the future development of CHS-targeting anti-candida agents, it is essential to
understand their structural and mechanistic differences for both catalysis and inhibition. As a preliminary study,
we heterologously expressed and purified catalytically active CaCHS1 and CaCHS2, and solved the cryo-EM
structures of CaCHS2 in the apo-, substrate-bound, and PN (nikkomycin Z and polyoxin D)-bound forms. We
also developed novel activity assays for the determination of chitin chain length and quantitation of both long
insoluble chitin and short soluble chito-oligosaccharides, and established a method for chemo-enzymatic
synthesis of nikkomycin analogs. Based on these developments, we propose to study the mechanism of chitin
formation and extrusion by CaCHS2 (Aim 1), the functional and structural basis of the lower susceptibility of
CaCHS1 to PNs as well as the synergy of using both CaCHS1 and CaCHS2 inhibitors (Aim 2), and the detailed
and systematic structure-activity relationships of PNs (Aim 3). For Aims 2 and 3, clinical isolates of C. albicans
and non-albicans candida strains will also be included for inhibitor testing, increasing the translational potential
of our research program. The proposed research is significant because it will provide the molecular basis for
future development of novel antifungals against a clinically unexploited target.

Public health relevance
Project Narrative The proposed research is relevant to public health because chitin synthases (CHSs) are highly promising and clinically unexploited targets of antifungal therapeutics, and existing CHS inhibitors exhibit in vivo antifungal activities against pathogens that cause endemic invasive fungal infections in humans. The proposed project will provide an atomic-level understanding of the catalysis and inhibition of CHSs from pathogenic fungi. Since such knowledge is critical for the future development of clinically useful CHS-targeting antifungal antibiotics, the proposed research is an important step towards combating fungal infections.